An Innovative AI-Powered Wearable Physiological Sensor System for Real-Time Pain Monitoring and Management (PainVitals)

PROJECT SUMMARY/ABSTRACT
This SBIR Phase I project focuses on the design and development of Pain Vitals, a non-invasive,
innovative wearable, and AI-supported biosensor system specifically designed for continuous and
objective pain monitoring and management. Approximately 80% of patients experience pain after
surgery. Of those who experience post-surgical pain, 86% report moderate, severe, or extreme
pain. About 88% of patients receive analgesic medications to manage pain, but 39% still report
moderate to severe pain even after receiving their first dose. In addition to causing patient distress
and anxiety, postoperative pain is associated with delayed discharge, increased morbidity,
persistent pain, prolonged consumption of opioids and higher health-care costs. These statistics
highlight the ongoing challenges in effectively managing post-surgical pain and the need for
improved pain management strategies. To address this public health emergency, Aventusoft
working with large healthcare systems in Florida is developing Pain Vitals. Placed comfortably on
user's chest via a biocompatible patch,
Pain Vitals continually monitors multiple physiological
parameters and provides an objective pain index for patients. In Phase I, we will complete the
development of
Pain Vitals AI-supported algorithm for continuous monitoring of pain level and
demonstrate through an IRB approved clinical testing that Pain Vitals respond better to noxious
stimuli than any individual parameter. A continuous, objective monitor will help reduce the
subjectivity in dosing analgesics, reduce the risk of overdosing or underdosing, and improve
patient safety during general anesthesia. Pain Vitals can help the clinician reduce the uncertainty
of drug effect and improve patient outcomes. The easy-to-use form factor of Pain Vitals will enable
careful titration of medications, improving the treatment and management of pain in the peri-
operative period and for continuation during home monitoring. Pain Vitals is based on our
commercial HEMOTAG Vitals FDA medical device of home monitoring for cardiac
decompensation. Encouraged by the availability of our HEMOTAG Vitals solution, we are now
applying for funding to facilitate the development and clinical validation of Pain Vitals. Pain Vitals
helps the development of improved pain management for acute and chronic pain conditions,
improved pain management and resulting in the enhanced continuity of care of patients with
chronic pain. This early-stage technology development through first in human demonstrations and
early feasibility clinical studies, reduces barriers to pain management in underserved and health
disparity populations. Provides new screening tools and will enable models that focus specifically
on pain and development of pain therapies.

Public health relevance
PROJECT NARRATIVE Overall, this project provides direct relevance to public health by facilitating new insights through the development of an innovative wireless, cardiac biosensor and machine learning algorithm useful for the rapid assessment of pain to enable precise diagnosis and improved treatment decisions, by modifying and monitoring treatments adequately. The novel device will significantly impact the current known methods for detection, monitoring, of pain, and support evidence-based clinical practice. The device will have great potential for many other etiologies as well.